Sex related differences in Brain Gut Microbiome Interactions in Irritable Bowel Syndrome

ABSTRACT
Irritable bowel syndrome (IBS) and chronic normal transit constipation (CC) are prevalent intestinal disorders
which are more common in women. In addition, female IBS patients experience more pain during low estrogen
states, e.g. during the luteal phase of the menstrual period and post menopause. Until recently, there was no
consensus about the pathophysiology of these disorders, no satisfactory long term treatments, and no reliable
biomarkers for guiding treatment decisions. However, there is increasing evidence that disturbances at
different levels of the brain-gut microbiome (BGM) axis play a central role in the pathophysiology of IBS and
possibly CC. This proposal is based on the general hypothesis that female sex hormones and gut microbial
metabolites play an important modulatory role on brain gut microbiome interactions, and that ascending
arousal systems originating in the brainstem may in part responsible for the altered cognitive, affective and
sensory processing function resulting in increased perception of visceral and other sensory signals,
maladaptive coping, and comorbid anxiety characteristic for patient with functional GI disorders. Therefore, the
overall goal of this proposal is to identify the sex-specific effect of gut microbial metabolites, and estrogen
levels on ascending arousal pathways originating in distinct brainstem nuclei to change the activity and
connectivity of brain networks involved in symptom generation. Using advanced brain imaging methods, gut
microbiome analyses, and detailed clinical phenotyping, as well as state of the art statistical and bioinformatics
tools, this proposal is addressing the hypothesis in 3 synergistic and closely related Projects, assisted by a
Leadership Administrative Core and a Data Processing and Analysis Core. Project 1 aims to study the
influence of natural low estrogen states and microbial metabolites on BGM interactions in female IBS patients
with IBS and CC in the luteal phase, and after menopause. Project 2 aims to clearly identify the brainstem
nuclei giving rise to ascending noradrenergic and serotonergic projections to limbic and cortical brain regions,
determine the influence of gut microbial metabolites on these arousal systems and determine differences in
these effects between male and female patients. Project 3 aims to evaluate the biological mechanisms within
the BGM axis that mediate the clinical effectiveness of cognitive behavioral therapy (CBT) in male and female
IBS patients, and identify possible predictors and mediators of outcome.The information garnered from this
study could reveal novel insight into the involvement of different levels of the brain gut microbiome axis in IBS
pathophysiology, and provide a powerful clinical tool for identifying the most effective therapeutic strategies for
women and men with functional GI disorders.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This SCORE proposals aims to gain a better understanding of the role of the gut microbiome and female sex hormones in the modulation of brain gut microbiome interactions in two of the most common disorders of the gastrointestinal tract, irritable bowel syndrome and chronic functional constipation. To achieve this goal it will study these interactions in 1) female patients during low estrogen states (perimenstrually, post menopausal); 2) by comparing these interactions between female and male patients and healthy control subjects and 3) by studying gut microbial and brain mechanisms underlying the effectiveness of cognitive behavioral therapy. Results obtained from the proposed studies are likely to lead to significant improvements in the treatment of these disorders.